Multilevel Panel Study of Effects of Changes in Nursing on Health Equity and Patient Outcomes

Determining the association of nursing on patients with intellectual or developmental disabilities in the
acute care setting
The NIH recently designated persons with disabilities as a health disparities population. The disparities
experienced by those with intellectual and developmental disabilities (IDD) include a greater incidence of
physical and mental ailments, increased morbidity and mortality, barriers to high quality care, stigma, biases,
social disadvantage, and marginalization. However, there is a gap in the literature about approaches to
reducing health disparities in the IDD population. Most research focuses on parents of IDD children, parents
who have IDD, care for those who have dual diagnoses of IDD and another health problem, challenging
behavior, and IDD caregiver burnout. To close the gap, we are proposing a supplement to R01NR014855 to
utilize data collected in the parent grant to undertake novel methods to create individual risk profiles, using
comorbidities, social determinants of health (SDOH) and IDD diagnoses, and to quantify the association of
nursing resource factors on the risk adjusted outcomes of adult patients with IDD. Intersecting comorbidities,
SDOH, and IDD diagnoses are expected to contribute to meaningful variation in clinical risk in the hospitalized
IDD population. Quantifying the variable risk arising at the intersection of IDD, comorbidities, and SDOH is
important because a particular challenge for this population is diagnostic overshadowing—when symptoms are
misattributed to IDD rather than comorbidities and social determinant factors. Diagnostic overshadowing
reduces quality of care and has been shown to lead to poor outcomes including increased mortality. Diagnostic
overshadowing occurs more frequently when providers face time pressures, have poor teamwork, and lack
resources. There is promising evidence that outcome disparities are reduced for other vulnerable populations,
such as patients with serious mental illness and those with opioid use disorder, when they receive care in
hospitals with better nursing resources, including increased nursing education, improved staffing, and more
supportive work environments. The extent to which nursing resources are associated with IDD hospital patient
outcomes is not known. The proposed study expands upon previous studies by: (1) quantitative research
methods to specify pathways by which nursing resources might decrease adult IDD length of stay or
readmission rates; (2) utilizing the secondary nursing data in the process of exploring adult IDD outcomes; and
(3) ultimately using comorbidities, SDOH and IDD risk profiles to estimate which adult IDD patients may
significantly benefit from greater nursing resources. Results will greatly improve our ability to target which
nursing resources may benefit adult IDD patients. The central hypothesis is that an investment in nursing
resources for the highest risk IDD inpatients will improve patient outcomes.

Public health relevance
Project Narrative Those with intellectual and developmental disabilities (IDD) have been designated by the NIH as a population with health disparities, reflected in increased morbidity and mortality rates, barriers to high quality care, stigma, biases, and ableism, and there is a gap in the literature about approaches for reducing health disparities in this population. We propose utilizing novel methods, including the creation of IDD patient risk profiles by including high risk combinations of comorbidities, social determinants of health, and IDD diagnoses, and then quantifying the association of nursing resource factors on the risk adjusted outcome of adult patients with IDD. The long- term goal is to reduce health disparities for IDD hospital patients through the appropriate deployment of nursing resources and the use of risk profiles.